Risk Pathways to Major Depression: Integrating Genetic-Epidemiological, Developmental, and Molecular Genetic Strategies in Danish and Swedish National Registers

Project Summary
This project seeks to advance our etiological understanding of Major Depression (MD) by clarifying the
interrelationships, over developmental time, of genetic and environmental risk factors. These analyses will be
conducted using data from Denmark and Sweden - two of the best and most complete population-based registers
in the world. Our investigative team brings together individuals with expertise in medical and psychiatric
epidemiology, genetic epidemiology, psychiatric nosology, and psychiatric molecular genetics as well as deep
experience working in Swedish and Danish registers. We propose seven specific aims. The first two involve
harmonizing a wide range of information relevant to risk for MD across the two registers, along with their unique
extensions, and then continued development of a methodological innovation key to this proposal: Family Genetic
Risk Scores (FGRS). FGRS permits us to assess, based on extensive pedigree information, profiles of multiple
genetic scores – capturing risk for MD, related disorders, and other traits that could help dissect etiology - in
every individual with family-linkage in the Danish and Swedish populations. Our third aim is to further develop
and validate registry-based measures of environmental stressors that reflect i) chronic psychosocial adversities
and ii) stressful life events, both of which predispose to MD, although over different time scales. The fourth aim
will be to describe differences in the FGRS profiles associated with key clinical characteristics of MD (e.g., age
at onset, recurrence, diagnostic stability) and psychiatric comorbidity (e.g., with anxiety or alcohol use disorders)
in Denmark and Sweden. The fifth and sixth aims are to integrate what we have learned about MD and its risk
factors to develop comprehensive etiologic models for MD that take into account genetic, environmental, and
developmental factors, as well as possible differences among subtypes of MD. All analyses using FGRS will be
paralleled using polygenic scores (PGS) in the set of individuals genotyped as a part of three Danish biobanks.
We hope these analyses can better flesh out etiologic heterogeneity within the broad MD syndrome. The final
aim, using molecular genetic resources from Danish biobanks, is to explore the impact for GWAS approaches,
guided by our previous aims, to inform on molecular mechanisms of MD. In sum, this project will find substantial
power, reproducibility, and robustness in working across comparable nation-wide health, socio-demographic,
and familial registers from Denmark (sampling from ~9,500,000 individuals, ~300,000,000 person-years of
observation) and Sweden (sampling from ~17,000,00 individuals, ~500,000,000 person-years of observation)
and leveraging extensions into primary care registers of Sweden and >500,000 genotyped individuals in Danish
biobanks. This project is of relevance to the US as it seeks to gain much needed insights into the etiology of
MDD that could guide, in the future, nosology, prevention, and/or intervention.
1

Public health relevance
Project Narrative This project seeks to identify a wide range of risk factors for major depression (MD) using the detailed information available in the national registries of Denmark and Sweden. We will obtain high quality family-based and molecular measures of genetic risk and registry-based measures of environmental risk and well as detailed clinical indices of heterogeneity in MD. From this information, we will estimate developmental models of risk to MD and its various subtypes so as to gain needed insights into the etiology of MD that could guide improved prevention, and/or intervention. 1